Swine Somatic Cell Gene Editing Testing Center

PROJECT SUMMARY: OVERALL
The overall purpose of this project is to provide services to the somatic cell genome editing community. Those
serviced include to 1) produce, import, cryopreserve, and supply swine biomedical models for the somatic cell
genome editing research community, 2) evaluate the safety and efficacy of somatic cell genome editing
strategies, and 3) determine the therapeutic value, window of opportunity, and duration of therapies. It is
anticipated that these services will advance basic research through testing of novel reagents as well as
facilitating translation of therapeutic interventions into the clinic. The role of the Genome Editing Coordination
Section will be to manage communication and logistics associated with Swine SCGE Center. These
responsibilities include reporting to NIH and regulatory agencies when appropriate as well as communicating
with Center Users, the Program Steering Committee, and various collaborators. The role of the Genome
Editing Resource Section will be to produce, import, cryopreserve, validate, and supply unique swine models.
The Resource Section will also maintain breeding colonies and produce cohorts of experimental animals, and it
will be responsible for assembly and maintenance of BSL2 facilities for use by the Testing Section. The role of
the Genome Editing Testing Section will be to provide novel delivery methods and reagents for the Somatic
Cell Genome Editing community. The Genome Editing Testing Section will streamline the testing process
while maintaining a comprehensive and rigorous comparative analysis of new genome editing tools and
delivery systems. Our group is ideally suited to provide this testing due to our unique composition of individuals
that are experienced with pig production, swine biomedical models, operate successful labs that routinely test
cutting-edge genome editing technology, and are associated with world-renowned National Swine Resource
and Research Center (NSRRC) and the sunsetting Swine Somatic Cell Genome Editing Consortium Large
Animal Testing Center.

Public health relevance
PROJECT NARRATIVE: OVERALL COMPONENT This project addresses an unmet need for essential services related somatic cell genome editing. This project will provide models that recapitulate human conditions and harbor human target sequences. Further, this project will provide testing services to evaluate safety and efficacy of potential therapeutic strategies.